ARC UE5 at the University of California San Francisco

ABSTRACT
The University of California San Francisco's (UCSF) Advanced Research Careers (ARC) HUB is designed to
provide comprehensive mentorship, training and career exploration for senior doctoral and postdoctoral scholars.
The UCSF ARC HUB's initiatives are designed to equip scholars for a seamless transition into roles as research
and teaching faculty or as researchers in the biotech sectors. Utilizing UCSF's established resources and
proficiency in career and professional development, the program integrates evidence-based strategies rooted in
career theory and proven methodologies aimed at doctoral and postdoctoral scholars. It provides platforms for
both guided and self-directed information gathering related to the three career foci of the HUB. The HUB also
offers innovative instruments for the identification and assessment of occupation related skills, knowledge, and
competencies. Additionally, it gives access to extensive data on national and local workforce capacities, salary
benchmarks, and growth projections.
Scholars will be onboarded in cohorts, establish their peer coaching groups, and participate in a 3-day HUB
Institute, providing them with a suite of professional development workshops and opportunities for networking.
Coaches are senior faculty and biotech professionals trained in coaching and relevant career theory. The
coaches will lead semi-structured monthly virtual meetups to discuss scholar progress as well as personal and
professional issues related to scholars’ professional path and development.
Finally, the program will provide monthly workshops on a variety of career related topics in the context of a four
stage career development framework. These topics include Career Planning, Networking Strategies, Negotiation
Skills, and Entrepreneurship and will be led by experienced professionals. Participants will also have access to
career guidance professionals through the Office of Career and Professional Development at UCSF. The
instruction and mentoring components of the program reflect the strengths-based approach designed to
maximize informed career decision making, enhance career self-efficacy and optimize preparation and
competitiveness for successful entry into the research workforce. As the program progresses and matures, we
look to develop a robust alumni network that will enhance the training activities, as well as provide ongoing
support, mentorship, and job opportunities.

Public health relevance
PROJECT NARRATIVE: This proposal aims to augment the training of doctoral students and postdoctoral fellows throughout the United States who are pursuing careers in the biomedical workforce following their doctoral training. These trainees rare the emerging generation of professionals uniquely equipped to tackle health care challenges and health disparities within their communities. We anticipate that these trainees to engage in research focusing on conditions such as hypertension, diabetes, obesity, breast cancer, and prostate cancer, which disproportionately affects underserved populations.